CRCNS: Data-efficient natural image reconstruction to advance visual neuroscience

PROJECT SUMMARY (See instructions):
We live in diverse environments featuring dynamic, interacting stimuli that can be viewed from an arbitrary
set of perspectives and approached under a variety of goal scenarios. However, modern cognitive and
visual neuroscience studies often stand in stark contrast to this reality of our lived experience: typically,
participants view isolated, simplistic stimuli while brain activation is recorded and reconstructed or decoded
neural representations are quantified. Reconstructing naturalistic visual images from fMRI data presents a
challenging task: existing approaches require dozens of hours of 7T fMRI data per participant and
extensive compute capability, each of which render these methods inaccessible to traditional cognitive
neuroscience labs. Our long-term goal is to develop data-efficient methods to enable use of natural stimuli
in cognitive neuroscience studies which characterize neural information content and transformations with
cognitive operations. Our objective in the present proposal, which is the next step towards our long-term
goal, is to demonstrate the efficacy of natural image reconstruction as an experimental tool in cognitive
neuroscience via implementing biologically-inspired optimizations to existing approaches and
benchmarking their performance on newly-acquired cognitive task data. Our work involves 3 specific aims:
(1) maximize data and computational efficiency of image reconstruction approaches, (2) improve image
reconstruction using neuroscience principles, and (3) investigate the impact of cognitive tasks on
reconstructions from neural representations of natural images. Across all Aims, we will implement and
optimize a novel Al-based image reconstruction approach applied to fMRI data. In Aim 1, we will focus on
establishing the efficacy of our approach for training decoding models for new participants using minimal
new fMRI data. In Aim 2, we will augment our method by incorporating principles from visual neuroscience
as informative priors, like spatial receptive fields estimated from retinotopic mapping and feature-selectivity
estimated from functional localizers. In Aim 3, we will test our approach by acquiring several benchmark
cognitive neuroscience datasets measuring how reconstructed representations are impacted by visual
cognitive task demands including visual attention and working memory. This work is innovative because it
enables natural image reconstruction with tractable datasets in cognitive neuroscience labs. This work is
significant because it will lead to a new understanding of the neural codes supporting visual perception,
attention, and working memory, which are impacted in a host of neurological and psychiatric disorders.

Public health relevance
RELEVANCE (See instructions): Improving the ability to use natural stimuli when measuring neural mechanisms of visual processing will better capture how brains interact with their natural environments, where cognitive impacts of dysfunction are most apparent. This will enable new insights into visual recognition, attention, and working memory, which are impacted in conditions like Alzheimer's disease, Schizophrenia, and anxiety/depression. Additionally, this may lead to new strategies for monitoring the efficacy of vision restoration techniques.